Host-pathogen molecular and cardiovascular interaction during influenza infection

This study is aimed to better understand cardiovascular physiological, biomarker, and viral genomic
heterogeneity changes from influenza infection onset to recovery during normal and differing inflammatory
states (obesity and antiviral treatment). Thorough investigation of the spatiotemporal inflammatory
biomarker profile along with the respiratory and cardiovascular physiological profiles from naivety to
recovery will allow us to explore the interplay between responses to influenza infection in primary site of
infection and its peripheral effects. The identification of novel biomarkers (molecular and proteomic)
during an inflammatory event could significantly improve predictions for cardiovascular events.
Additionally, more thorough genomic investigation of replicating influenza populations can lead to better
surveillance and prediction of ongoing and emerging events. This study will investigate a major gap in
knowledge by performing detailed analysis of cardiovascular and molecular changes associated with
localized respiratory viral infection with obesity and antiviral treatment or chemoprophylaxis. We hope to
modify cardiovascular events caused by respiratory virus infection (both during and after) with
pro-inflammatory state of obese mice or reduction of inflammatory events in a timely manner with varying
oseltamivir treatment timings. The expectation is to define markers that are present during an influenza
virus infection that correlate with disease and changes in physiological homeostasis specifically for each
inflammatory state (proinflammatory caused by obesity and anti-inflammatory caused by antivirals).
Overall, we hypothesize that a localized inflammatory event in the respiratory system caused by the
influenza virus infection leads systemic changes in normal cardiovascular physiology, biomarkers, and
viral genomic heterogeneity that can be altered by obesity and timely admission of antiviral therapeutics.

Public health relevance
We hypothesize that local inflammatory events in the respiratory system from influenza virus infection leads to systemic changes in normal cardiovascular physiology that can be altered with bodyweight and timely admission of antiviral therapeutics. Changes in cardiovascular physiology, biomarkers, and viral genomic heterogeneity will be investigated from onset to recovery in influenza infection in mice with obesity and antiviral prophylaxis or treatment.